Machine Learning and Longitudinal Analyses of Metformin Response Among Veterans

Type 2 diabetes mellitus is a chronic disease that may be amenable to precision medicine approaches
because it affects a large, diverse segment of the population. In fact, the VA and American Diabetes
Association guidelines recommend individualization of diabetes management, yet initial diabetes treatment is
rarely individualized in current routine clinical care. The vast majority of diabetes patients are initially treated
with metformin, and over a quarter of these patients fail to respond to metformin alone, leading to delays in
achievement of early glycemic control and potentially avoidable risk of diabetes complications. There is a
paucity of validated strategies to individualize initial diabetes treatment. Thus, precision medicine approaches,
which attempt to match optimal disease management strategies to characteristics of an individual patient, are
ideal to address the evidence gap to systematically guide individualized diabetes care. Individualized or
precision medicine treatment is common in cardiovascular disease care, where clinical risk prediction tools
guide drug selection (e.g., anticoagulation in atrial fibrillation) and treatment intensity (e.g., cholesterol goals on
statin therapy). We propose a similar approach for diabetes treatment individualization based on prediction
tools that estimate risk of diabetes complications and glycemic response to metformin.
The overall goals of this career development award (CDA) are to develop and validate prediction
tools that inform individualized diabetes care. The first two aims of the proposal are designed to determine
patient characteristics at the onset of treatment that predict diabetes-related complications (Aim 1) and
glycemic response to metformin (Aim 2). In Aim 3, we will evaluate whether these prediction models can inform
treatment approaches to achieve improvements in long-term diabetes complications. We will leverage large VA
data repositories to create two independent cohorts of Veterans with type 2 diabetes to complete the aims of
this proposal and form the basis of additional future observational studies. This study is innovative in that it
leverages real-world clinical data from Veterans to generate evidence to guide precision medicine
interventions; uses machine learning approaches and longitudinal methods to capture information from
repeated measurements in routine clinical care to make maximal use of electronic health record data; and
focuses on prediction tools based on data available at the time of diabetes diagnosis to guide initial treatment.
The career development plan aligns research aims with training aims in order to prepare the
applicant to undertake a research career focused on applications of precision medicine to improve
Veteran health. The training goals of the proposal are focused in three areas that share a common theme of
maximizing longitudinal VA clinical data for clinically-relevant observational research: 1) machine learning
approaches applied to a clinical database; 2) longitudinal methods, including growth mixture models, that
enable identification of patterns in repeated clinical measures; 3) methods for causal inference using large-
scale observational data. Upon successful completion of the proposed scientific and training aims, the
applicant will be prepared to pursue precision medicine studies focused on the use of newer diabetes drugs,
incorporation of genetic data into clinical prediction models, and evaluation of the effect of prediction model use
in routine diabetes care. The diverse mentorship team has content expertise in diabetes and cardiovascular
disease, and methodological expertise in machine learning, longitudinal epidemiological studies, and causal
inference. Direct mentorship will be paired with coursework and seminars to fill gaps in the applicant’s training
and ensure progress towards independence as a clinician-investigator. Finally, the environment is ideal for the
applicant’s career development, including resources available through the VA HSR&D Denver-Seattle Center
of Innovation for Veteran-Centric and Value-Driven Care and the University of Colorado School of Medicine.

Public health relevance
Type 2 diabetes affects almost a quarter of Veterans and negatively impacts Veteran health by increasing the risks for heart, kidney, and eye disease. Diabetes patients represent a diverse population, and the method of selecting the best initial diabetes treatment approach for each patient remains unclear, even though guidelines recommend individualized tailoring of treatment. The proposed research applies state-of-the-art computational and epidemiologic methods to explore VA clinical data to determine if there are factors that can accurately and reproducibly predict a patient’s risk of developing diabetes complications in the future and his/her likelihood of responding to metformin, the most commonly used initial treatment for diabetes. The study will then test whether applying prediction models to guide risk-based selection of initial diabetes treatment might have clinical benefits for patients. The study will inform individualized diabetes care, serve as a model for precision medicine methods to study chronic diseases, and contribute to improving Veteran health.